Development of Biodegradable Nanocarrier for Improved Co-delivery of PARPi and DNMTi

While PARP inhibitors like BMN673 (Talazoparib) have shown significant effectiveness in treating cancers
with homologous recombination (HR) deficiency, their benefits are limited for HR-proficient cancers. The
combination of a DNMT inhibitor (DNMTi) such as 5-azacytidine (AZA) with PARPi has been shown to
enhance efficacy by inducing HR defects. However, the application of this combination is challenged by the
poor bioavailability and the off-target toxicity of both drugs. Efficiently co-delivering PARPi and DNMTi via
nanocarriers is complex due to their differing physicochemical properties and the challenge of achieving
precise tumor targeting. Once entering biological fluids, most NPs acquire a protein corona that dictates
their biological identity and behavior in the body, complicating the design of nanocarriers for predictable
and enhanced tumor targeting. In our preliminary studies, we developed a small sized nanocarrier based
on AZA-conjugated polymer that could efficiently load BMN673. The new formulation was more effective in
suppressing tumor growth in PARPi-insensitive NSCLC tumor models compared to free drug combinations.
PAZA nanocarrier demonstrated excellent tumor penetration due to a new mechanism of active targeting
that involves the recruitment of fibronectin from serum proteins following systemic administration. However,
the complexity of precisely controlling the protein corona, influenced by variables such as polymer structure
and molecular weight, poses a significant challenge and impacts the nanocarrier's behavior in biological
systems. In addition, the current PAZA carrier is non-biodegradable, which may accumulate in the body
over time, raising concerns about its long-term safety. To address these issues, the first objective is to
develop biodegradable bPAZA carriers and evaluate the impact of polymer structure on the protein corona
composition. A detailed understanding of how NPs interact with serum proteins and the impact on
biodistribution will allow for precise modulation of protein corona. The second objective focuses on
conjugating cetuximab, a monoclonal antibody targeting EGFR, to a bPAZA carrier exhibiting minimal
protein corona. By leveraging the benefits of cetuximab's dual role as a targeting agent and a therapeutic,
the proposed work will provide a new AZA-based nanocarrier with improved specificity and efficiency for
enhanced PARPi based synthetical lethal therapy.